CHARACTERIZATION OF FAMILIAL MYOPATHY, PAGET DISEASE OF BONE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This umbrella study will incorporate the current study, HS# 2007-5832 with another UCI IRB-approved study, and the current study's predecessor, HS# 2007-5607. Upon incorporation as part of E-MOD #6222, HS# 2007-5607 will be submitted for closure and HS# 2007-5832 (the current study) will incorporate the samples and findings of the previous research at these sites, and will unites all future IBMPFD research at UCI into one protocol.